RR&D Research Career Scientist Award Application

Dr. Pardue’s research program is centered on developing life-changing treatments for veterans with
vision loss. She has made significant contributions in three research areas: a) treatments for retinal
degeneration, b) early detection and treatment of diabetic retinopathy, and c) retinal mechanisms of refractive
development. Pre-clinical studies from her research program have enhanced our understanding of
mechanisms that underlie blinding diseases and advanced new treatment options. Her dual position between
the VA and Georgia Tech creates a unique situation to leverage resources and collaborations to move new
technologies into the clinic. She is a firm believer that collaborative research is essential to translate results
from bench to bedside. This is reflected in over 75% of her 89 publications stemming from collaborations with
over 46 different investigators. Moreover, her findings have formed the basis for 3 areas of translational studies
to human patients (retinal prosthetics, diabetic retinopathy, and neuroprotection therapies). Dr. Pardue’s dual
appointment and research interests create novel opportunities to draw parallels and intersections between
different systems and fields of study with the potential for ground-breaking discoveries.
Dr. Pardue’s commitment to teaching and mentorship are illustrated by a number of roles. She has
lectured to undergraduate and graduate students on the retina and visual system for the last 18 years and
been the instructor for 7 courses. Dr. Pardue has a strong interest in professional development and has
organized and taught courses for post-docs and graduate students on this topic at the VA, Emory, and Georgia
Tech, as well as at international conferences. In addition, she actively supports women in science at the
graduate and junior faculty levels through institutional and international programs. Dr. Pardue has mentored 5
VA Career Development Awardees (CDAs). Over 80% of the students that she has mentored have continued
on in medicine or science.
Dr. Pardue has consistently served the scientific community throughout her career. Specific to the VA,
Dr. Pardue chaired the IACUC Committee from 2004-2008 and has chaired the R&D Committee for the last ten
years (2008-date). She assisted with two successful renewal cycles of the Atlanta VA Rehab Center. As the
Associate Director of Scientific Projects, she directed the internal review process of all Rehab Center
submissions, increasing the funding rate to 20% for Merits and 42% for CDAs. She currently serves as the
interim Associate Director of the CVNR. She also serves on the Advisory Board for the Atlanta VA non-profit
foundation (AREF). On the international level, she has served on several committees for ARVO and was
awarded their prestigious Silver Fellow Award in May 2016. Dr. Pardue has served on many study sections
from NIH, VA, and various national and international private foundations. She currently serves as a regular
member of NIH Neuroscience and Ophthalmic Imaging Technologies (NOIT) study section. Her contributions
and leadership in the field was recognized in 2017 by induction as a fellow into the American Institute of
Medical and Biological Engineers (AIMBE).
Dr. Pardue’s future goals are to 1) develop new rehabilitation strategies for blinding diseases, 2) identify
the earliest signs of diabetic retinopathy and determine early interventions to slow the progression of vision
loss, and 3) determine the role of dopamine in refractive eye growth. These goals are grounded in the results
from her laboratory over the last several years, including the increased number of publications in high impact
journals. Based on prior success, she anticipates the development of new treatment strategies. Translation of
these findings from the laboratory to the clinic will be facilitated by her collaborations within the CVNR and
clinicians at the VA. Thus, these projects support both the common theme of understanding and treating retinal
disease to prolong functional vision and the VA mission of improving healthcare for veterans.

Public health relevance
Dr. Pardue’s research program is centered on developing life-changing treatments for veterans with vision loss. Her pre-clinical research in the areas of neuroprotective treatments for retinal disease, detection and treatment of diabetic retinopathy, and mechanisms for myopia or near-sightedness have formed the basis for 3 translational studies to human patients (retinal prosthetics, diabetic retinopathy, and neuroprotection therapies). Dr. Pardue’s dual appointment between the VA and GaTech and her research interests create novel opportunities to develop ground-breaking treatments that can preserve or halt vision loss.